A Portable, Low-Cost, Pont-of-care Microfluidic System for Rapid Pharmacogenomic Screening of Patients with Major Depressive Disorder

Project Summary/Abstract
The current approaches to prescribing medication to patients with major depressive disorder (MDD) involve a
‘trial and error’ approach to prescribing selective serotonin reuptake inhibitors (SSRIs) based on patient interview
and physician insight. Unfortunately, a high percentage of trials fail on the first try and after two or more ‘failed’
drug treatments, patients are considered “treatment resistant.” Relevant research has elucidated that
liver cytochrome P450 (CYPs) enzymes are responsible for carrying out a series of oxidations
that metabolize drugs as part of a pathway to excretion. As such, the expression of the 57 CYP enzymes coded
for by the CYP genes determines how rapid an individual metabolizes a particular drug and, not surprisingly, this
varies dramatically from one patient to another. This is important because ‘rapid metabolizers’ often DO NOT
hit the critical systemic thresholds needed of the drug to be effective, while ‘slow metabolizers’ tend to
accumulate drug and, hence, reach levels that are often toxic and riddled with side effects, including suicide. In
fact, clinical responses to the same dose of a drug can vary among individuals based on single nucleotide
variants (SNVs) in CYP genes, especially CYP2D6 which metabolizes up to >25% of all drugs prescribed today
in medical practice and plays an important role in targeted drug selection, optimization of dose, and prevention
of toxicity. CYP2C19 is another candidate enzyme, whose genetic variations are known to control the metabolism
of many phototropic medications. Despite a considerable public database containing genome-to-phenome
information on these enzymes, the only current method to interrogating those SNPs and their effect on
the ‘metabolizer status’ of a patient, is sequencing the patient sample in a clinical testing lab, which is costly and
slow (1-2 weeks), and during that time, if the prescribed treatment plan is ineffective, there can be serious
consequences for the patient. Hence, we propose to use these CYP alleles to define patient ‘metabolizer status’
as fast, moderate or slow, at the point of patient care and avoid the ‘trial and error’ approach. We will develop a
point-of-care (POC) rapid assay for the pharmacogenetic screening of MDD patients. This microdevice will
require minimal physician intervention beyond collection of a patient buccal swab and placement of the swab
into the system for swab-to-genotype analysis. In less than 1 hour, physicians will be endowed with actionable
data with regard to MDD therapy, including an SSRI therapeutic recommendation and dosing suggestion.

Public health relevance
Project Narrative - public health relevance The current approaches to prescribing medication for patients with post-traumatic stress disorder and major depression disorder are inadequate, as clinicians are forced to use a trial-and-error to determine the best course of treatment. It is possible to analyze a patient’s DNA to determine if their metabolism will cause a positive therapeutic response or have serious negative side effects, but current methods are expensive and take multiple weeks to return results. We plan on creating a simpler test that can be carried out in the clinicians office < 1 hour, and while it won’t provide the same breadth of information as the more expensive test, the results are immediate and enhances the chances that the clinician prescribes the correct medication, potentially avoiding adverse effects such as toxicity and ineffective levels.